Algorithmic improvements in large scale polarizable QM/MM simulations

Project Summary
Modeling of chemical reactivity in heterogeneous environments such as protein pockets and complex solvents
is an essential part of a drug discovery workﬂow. However, such modeling is challenging, due to large system
sizes and necessity of extensive sampling of environment degrees of freedom. The goal of this project is to
develop a suite of efﬁcient, accurate and scalable computational tools based on the polarizable quantum me-
chanics / effective fragment potential (QM/EFP) methodology that will provide academic and private industry
users with fast and robust software for the computational characterization of free energy proﬁles of chemical
reactions in complex condensed phase systems. Phase II of this project builds upon the outcomes of a success-
ful completion of Phase I, in which the team has developed algorithms and computer codes that dramatically
decrease the computational cost of EFP and QM/EFP simulations by employing fast multipole method (FMM).
In Phase II the team will further improve the efﬁciency of FMM-QM/EFP codes by implementing robust par-
allel algorithms. Modeling of chemical transformations will be enabled by development of analytic nuclear
gradients and second derivatives. Additionally, FMM-QM/EFP will be interfaced with polarizable continuum
models (PCM) and extended to periodic boundary conditions that will provide users with complimentary tools
for modeling long-range electrostatic and polarization interactions. New methodology will be validated on
established and emerging data for mechanisms and energetics of solution-phase and enzymatic reactions.

Public health relevance
Project Narrative Novel software will be developed for computer modeling of chemical reactivity in proteins and solvents. The software will facilitate research tasks throughout computer-aided drug development workﬂows.